Building an “AI Forest” to identify the social and environmental factors underlying complex behavioral traits in wild primates.

PROJECT SUMMARY/ABSTRACT
With the advent of new technologies to probe brain-behavior relationships deeper than ever before, the field of
behavioral neuroscience finds itself at a crossroads for translation. The rich theoretical foundations upon which
many behavioral assays are based have largely been lost; and factors known to impact motivated behavior,
such as social and environmental challenges, tend to be ignored. Here, the rich neurobiological understanding
that has been obtained from captive animals will be leveraged to assess individual differences in motivated
behavior that derive from social and/or environmental adversity (or advantage) in a natural environment.
Laboratory-based paradigms will be brought to a wild population of ~350 white-faced capuchin monkeys
(Cebus imitator) living in a small, tractable forest in Costa Rica (Taboga Forest Reserve). Approximately 70 of
these capuchins have been tracked and studied near-daily for the past 7 years, generating a rich life-history
database for these individuals. These capuchins are habituated to humans and readily interact with stimuli on
experimental platforms. But importantly, they are also exposed to the natural elements – predators, droughts,
disease, and social adversaries – without human intervention. This project will lay the groundwork for an
Artificial Intelligence (AI) Forest that will transform our ability to study these animals as they develop, live, and
die in their natural environment. The AI Forest will be the first of its kind; an experimental forest allowing us to
probe laboratory-based behaviors in a wild primate population. Smart testing stations will be placed throughout
the forest to assess reward valuation, inhibitory control, and behavioral flexibility. A visual deep-learning
algorithm will be harnessed to recognize individuals as they voluntarily approach and perform at testing
stations. The AI system will automatically guide capuchins through experiments, allowing them to “self-pace”
as they complete each assessment. Data collection at the smart testing stations will be automated, potentially
yielding the largest dataset of its kind from a wild primate population. In addition, a vocal deep-learning
algorithm will be used to track movements of individuals and groups and to detect their social and
environmental challenges (intergroup and predator encounters). The multidimensional behavioral and
environmental data will be integrated to examine the impact of environmental adversity (or advantage) on
behavioral traits across the lifespan. This AI Forest represents an exciting possibility of what the future of
behavioral neuroscience could be – bridging studies of complex behaviors with function (adaptive evolution) –
to inform translational science and ultimately enhance our understanding of human health and disease.

Public health relevance
PROJECT NARRATIVE This project will establish a foundation for an Artificial Intelligence (AI) Forest that will transform our ability to study non-human primates in their natural environment. This work will enable the collection of multidimensional behavioral and environmental data that will enhance our understanding of complex brain-behavior relationships and ultimately inform translational science.